Biostatistics Core

Biostatistics Core: Summary/Abstract
The goal of the Biostatistics Core is to ensure that sound designs and statistical analyses are used to meet the
overall goals of ADNI4. The ADNI4 application will extend the follow-up of a large portion of the ADNI3 cohort,
deepening our understanding of the long-term processes underlying cognitive aging. Moreover, ADNI4 will recruit
and follow a new cohort that is more diverse in pathophysiology, current use of disease-modifying treatment,
socio-economic status (SES), and underrepresented populations (URPs, e.g., Black, Latinx.) As ADNI’s experts
in biostatistical methods and the data across cores, we will collaborate with other ADNI leaders on design and
analyses for each research theme: characterizing change, identifying predictors, improving clinical trial design,
and discovery.
Our Aims are: 1. To support a dynamic sampling plan that will use a broad registry combined with plasma-
based screening to obtain a diverse longitudinal cohort, enriched for biomarker study. 2. To provide guidance
and support for interim and final analyses, including the Project. 3. To collaborate with other Cores on statistical
methods for harmonization across platforms and ligands. 4. To develop new statistical methodology supporting
ADNI4 goals, especially in the area of longitudinal models of multiple biomarker trajectories and as needed to
address challenges arising from the ADNI4 sampling plan. 5. To provide intellectual leadership and foster
communication among biostatisticians interested in ADNI, including sharing of analysis vignettes through LONI
and a public Git repository, and extending our widely used, publicly available ADNIMERGE package.